Novel function of a mitochondria phosphatase in cardiac development

PROJECT SUMMARY
Mitochondria are essential for cardiomyocyte (CM) differentiation and cardiac morphogenesis. Mutations in
genes encoding mitochondrial proteins frequently result in congenital heart disease, highlighting the need to
elucidate key molecular pathway(s) in mitochondrial homeostasis during heart development. Protein Tyrosine
Phosphatase localized to the Mitochondrion 1 (PTPMT1) is a dual-specificity mitochondrial phosphatase
encoded by nuclear DNA. PTPMT1 is exclusively localized to mitochondria, being anchored to the inner
mitochondrial membrane. PTPMT1 is expressed in CMs throughout several developmental stages. To
determine the role of PTPMT1 in CMs, we generated a Ptpmt1 constitutive CM-specific knockout (cKO) mouse
model. Our preliminary data revealed that Ptpmt1 cKO mice display embryonic lethality. Ptpmt1 cKO mice
displayed thinner compact zone myocardium, with decreased CM proliferation. We also observed significantly
decreased mitochondrial respiration rate and abnormal mitochondrial morphology in Ptpmt1 cKO hearts,
demonstrating that PTPMT1 plays a critical role in developing CMs and in maintaining normal mitochondrial
homeostasis. We also examined previously described PTPMT1 substrates in Ptpmt1 cKO hearts relative to
controls, but could find no evidence to support them being direct substrates of PTPMT1 in CMs. To gain further
insight into pathways affected by loss of PTPMT1, we performed RNA-seq analysis of Ptpmt1 cKO hearts.
Bioinformatics analysis revealed that loss of PTPMT1 significantly activated the Activating Transcription Factor
4 (ATF4) pathway. ATF4 controls expression of a wide range of adaptive genes that allow cells to survive
periods of mitochondrial stress. However, under persistent stress conditions, ATF4 promotes induction of cell-
cycle arrest, apoptosis and senescence. Notably, reduced expression of ATF4 in global Atf4-haplodeficient and
smooth muscle-specific Atf4 knockout mice attenuates ER stress and reduces medial and atherosclerotic
calcification, highlighting new opportunities afforded by favoring a stress-relief adaptive effect over a
maladaptive effect by modulating ATF4 activation. The foregoing evidence leads us to the hypothesis that
PTPMT1 plays an essential role in cardiac development through modulation of specific substrates, and that
partial loss of ATF4, activated in response to mitochondrial stress in Ptpmt1 knockout CMs, may ameliorate,
but complete loss of ATF4 may exacerbate, Ptpmt1 cKO phenotypes. Accordingly, our specific aims are to: 1.
Elucidate the role of PTPMT1 in CM mitochondrial homeostasis and cardiac development and function by
analyzing Ptpmt1 cKO mice, and to identify endogenous substrates of PTPMT1 in CMs by performing
unbiased lipidomics and phosphoproteomics analyses; and 2. Determine the consequences of partial or
complete loss of ATF4 in CMs on phenotypes of Ptpmt1 cKO mice by analyzing CM-specific Ptpmt1
knockout/Atf4 heterozygous (hcKO) knockout mice and CM-specific Ptpmt1/Atf4 double knockout (dcKO) mice.

Public health relevance
PROJECT NARRATIVE Mutations in genes encoding mitochondrial proteins frequently result in congenital heart disease, highlighting the need to elucidate key molecular pathway(s) in mitochondrial homeostasis during heart development. Protein Tyrosine Phosphatase localized to the Mitochondrion 1 (PTPMT1) is a mitochondrial phosphatase, exclusively localized to mitochondria. Proposed studies will help us to understand the biological function of PTPMT1 in cardiomyocytes at the molecular, cellular, and physiological levels, and determine consequences of partial or complete loss of Activating Transcription Factor 4 (ATF4), a master transcriptional regulator of the mitochondrial stress response, on phenotypes of Ptpmt1 cardiomyocyte-specific knockout mice.